Clinical Core

PROJECT SUMMARY/ABSTRACT
Clinical Core (Core C)
The mission of the HU CFAR is to expand, promote, and facilitate collaborative innovative multidisciplinary
HIV/AIDS research among its members to bring an end to the HIV epidemic. Critical to this mission is the
Clinical Core, which provides essential resources to support and foster clinical and translational research
among clinical, social, behavioral, and basic scientists. The primary goals of the Clinical Core are to facilitate
access to clinical research databases, to provide regulatory support to CFAR investigators, to integrate access
mechanisms for acquiring and storing blood and tissue samples from people living with HIV, and to catalyze
collaborative cohort studies. These efforts include close linkages to and communication with HIV affected
communities and engagement of research participants in populations disproportionately affected by HIV. The
impact of the Clinical Core extends well beyond Boston, by providing a linkage to multiple international sites of
Harvard-based HIV/AIDS research and through a series of innovative and wide-ranging educational programs
designed to facilitate clinical research. The components of translational research supported by the HU CFAR
Clinical Core are either not funded or are only inadequately funded by other support mechanisms, and thus the
value added of this Core has been immense.
While the mission of the Clinical Core remains to facilitate clinical and translational research, the Core
continues to evolve and modify its programs to meet the emerging needs of investigators. Among new
initiatives outlined in this proposal are: a) expansion of HIV cohorts available to investigators, with a special
focus on high-priority populations and tissue sampling; b) upgrading database infrastructure for clinical cohorts;
and c) new resources to facilitate interactions with the community and collaborations. To meet the ongoing
needs of CFAR investigators, we will accomplish the following specific aims:
1. To expand essential infrastructure support for HU CFAR investigators conducting clinical and basic
science research related to HIV infection, HIV-associated comorbidities and coinfections, populations
disproportionately impacted by HIV, and HIV prevention.
2. To develop and provide access to databases and clinical specimen repositories from a greater number
and variety of well-characterized HIV cohorts.
3. To support novel educational and outreach programs designed to facilitate clinical and translational
research at HU, HU CFAR-associated sites and CFAR-affiliated international sites.